Vector Development Core

PROJECT SUMMARY – CORE B
The main function of Vector Development Core (VDC) B is to develop new lentiviral vectors (LV) and the
means for their production in order to facilitate their use in clinical trials proposed in Projects 1, 2, and 3. Core
B will achieve this aim by 1) producing small-scale vectors including LV, IDLV, and AAV for preclinical testing;
2) exploring new methodologies for vector manufacturing such as transient transfection in suspension cells and
stable cell line production systems; 3) developing next generation producer cell lines from suspension cells
growing in serum-free media; 4) developing process for scale-up manufacturing that bridges laboratory
research to cGMP production; 5) optimizing protocols for LV transduction of human hematopoietic stem cells
(HSCs). As such, Core B provides a critical link between the Projects and cGMP production in Core C by
performing developmental studies, by providing the scientific expertise for process transfer, and by providing
novel and unique reagents, vectors, and cell lines for these purposes. These research activities in Core B will
ultimately integrate into all projects for improved vector manufacturing and cell transduction.

Public health relevance
PROJECT NARRATIVE – CORE B Core B is essential to develop lentiviral vectors for clinical gene therapy of sickle cell disease and novel platform using suspension-based vector manufacturing that will increase potency of vectors and reduce manufacturing costs.